Mitochondrial complex-I as a target for metabolic resuscitation in perinatal hypoxic-ischemic brain injury

SUMMARY A worldwide mortality from perinatal hypoxic-ischemic insult reaches 1.2 million annually. In the US, perinatal HI-brain injury remains one of the major causes of cerebral palsy (CP) and life-long neurological disability. The life-time cost for patients with CP was estimated to reach 11.5 billion dollars. This dictates a need for therapeutic strategies based on better understanding the mechanisms of HI injury. We propose that, upon reperfusion, inhibition of complex-I recovery with novel compound, MitoSNO, protects developing brain against HI injury. MitoSNO is mitochondria-targeted agent that maintains C-I in the de-active form (D) via S- nitrosation of Cys-39 residue. Because, the reactivation of the C-I supports a reverse-electron transport mechanism of ROS production, the proposed mechanism of neuroprotection is attenuation of the reperfusion- initiated oxidative stress and protection of the D-form from irreversible oxidation of thiols. Aim 1 determines a contribution of succinate-dependent mitochondrial respiration to accelerated ROS generation and to bioenergetics recovery initiated by the reperfusion. Mechanistically, this aim provides the rationale for inhibition of complex-I recovery to block reverse electron transport, the mechanism for ROS generation burst in reperfusion. Aim 1 and 2 determines whether transient inhibition of C-I recovery with MitoSNO attenuates mitochondrial oxidative damage and preserves mitochondrial tolerance to Ca++ induced development of mPTP, and whether this limits the severity of secondary energy failure. Aim 2 addresses specificity of MitoSNO neuroprotective action to the S-nitrosation the Cys39 in the D-form of the C-I. Aim 2 also evaluates long-term neuroprotective effects of the MitoSNO. This project offers a strong mechanistic background for the development of clinically relevant and novel therapeutic strategy of metabolic resuscitation in which gradual metabolic recovery is the mainstream principle.

Public health relevance
Project Narrative. Perinatal hypoxic-ischemic brain injury is one of the major causes of permanent neurological deficit in children. Our proposal offers novel mechanistic understanding of mitochondrial dysfunction and mitochondria- driven oxidative stress following perinatal hypoxic-ischemic insult.